Development and characterization of anti-P. gingivalis peptides

Periodontitis is the 6th most common infection worldwide and an estimated 5 – 20% of the population suffer
from generalized chronic periodontitis. Studies based on the National Health and Nutrition Examination Survey
(2009-2010) data demonstrated that the incidence of periodontitis is significantly higher in African Americans
(AAs, 58.6%) and Hispanic Americans (HAs, 59.7%) compared to Caucasian Americans (CAs, 42.6%).
Periodontitis may also have systemic health consequences leading to conditions such as cardiovascular
disease, diabetes, and preterm birth, all of which are also considered disproportionally affect AAs and HAs.
Microbiome is recently considered to be an important contributor to these health disparity diseases and
conditions. Porphyromonas gingivalis, a gram-negative bacterium, has been recognized to play a vital role in
the development of dysbiotic microbial communities and is capable of disrupting host-microbial homeostasis
and inducing inflammatory responses in periodontal tissues facilitated by poly-microbes acting in concert. We
recently identified a potential functional motif (SAPP), located at the C-terminal portion of S. cristatus ArcA,
which can bind to surface proteins of P. gingivalis and repress the expression of fimA, mfa1 and rgps in P.
gingivalis. These exciting findings provide the foundation for the proposed studies. Our overall hypothesis is
that the components of the antagonistic communication system between S. cristatus and P. gingivalis can be
developed to identify compounds that repress virulence factor expression and pathogenicity of P. gingivalis.
The objective of this proposal is to dissect SAPP and identify the cognate P. gingivalis receptors. Therefore we
will first characterize and design small peptides derived from SAPP that repress expression of virulence-
associated genes in P. gingivalis. The receptor(s) of P. gingivalis that senses SAPP will then be identified and
characterized. Successful completion of the proposed studies will provide fundamental novel information
regarding interspecies antagonism, and could have far-reaching consequences on periodontal health by
leading to discovery of potential pharmaceutical agents to inhibit P. gingivalis colonization and pathogenesis.

Public health relevance
Project Narrative Periodontitis, a disease affecting a large proportion of the population, is associated with a dysbiotic microbial community in which Porphyromonas gingivalis is a major player. As current therapeutic options for periodontitis are only partially successful, therapeutic agents that can specifically target P. gingivalis are attractive and advantageous alternative over conventional antibiotics. Our proposed research will provide a molecular basis for the rational design of agents that can interfere with the initiation and formation of P. gingivalis-associated pathogenic communities.